Integrate Data-Driven Modeling and Multi-scale Measures Towards Tissue Function

Human tissues are highly organized structures with specific collagen matrix arrangements and the
resulting mechanical properties varying from point to point. The effects of such heterogeneity play an
important role for tissue function and failure. However, fundamental challenges present in understanding
how heterogeneity affects the growth and remodeling of various tissues and the related mechanical
performance of these tissues, due to limited knowledge on understanding of the multi-scale interactions
between cell signaling and heterogeneous matrix remodeling and their roles in tissue function.
The central theme of this proposal is to develop a novel bio-mathematical framework that dynamically
integrates physics-based and d ata-driven modeling approaches with experimental measurements, to
capture cell-matrix interactions in tissue multi-scale behavior and function. We aim to improve the
fundamental understanding of the underlying biological and mechanical implications o f matrix
heterogeneity, and advance towards our ultimate goal of providing a digital twin model for in-vivo tissue
degeneration on aneurysm growth. The team, formed by three Pl/Co-ls with complementary expertise on
scientific machine learning, experimental tissue biomechanics, and biological tissue modeling, plans to
ad vance on theoretical, computational, and experimental as pects towards the knowledge of
fi broblast-medi ated extracellular matrix (ECM) remodeling via three specific aims: (i) A multi-scale
data-driven model will be developed to concu rrently couple our intra-cellular signaling network model, a
novel agent-based cell population model, and a peridynamics model of tissue mechanics; (ii)
E
nriched by
advanced multi-task/multi-modal operator learning techniques, an information-theory based model
adaptation-experimental design integration pipeline will be developed; and (iii) New quantitative
knowledge on long-term fibroblast-mediated ECM remodeling will be obtained and validated through both
in-vitro and ex-vivo experiments. As a result, our combined in-vitro/ex-vivo experiments and multi-scale
model will help identify for the first time how heterogeneity affects tissue remodeling and the related
mechanical behaviors of tissue. The identified key features and optimized model forms enable the
learning from small data regime, providing a step-stone towards the digital twin modeling f or in-vivo
aneurysm growth. The proposed model will have significant impacts on transforming our understanding of
the roles of cell functi ons for determining tissue structures/mechanics, and thereby enabling model-based
virtual screening to identify and optimize therapeutic interventions. Our multi-scale model will of fer a
powerful prediction tool to the multi-scale biological mechanisms in many other bio-tissue systems, such
as blast-induced traumatic brain injury, aging of cartilage tissue, and bone reconstruction.

Public health relevance
RELEVANCE (See instructions): Biological tissues are highly organized structures with heterogeneous collagen matrix arrangements. However, fundamental challenges present in understanding how such heterogeneity affects the growth and remodeling of various collagenous bio-tissues, due to limited knowledge on holistic understandings of the multi-scale interactions between cell signaling and heterogeneous matrix remodeling. To address this critical need, the data-dri ven multi-scale approaches proposed herein will provide new insights into the underlying biological and mechanical implications of matrix heterogeneity.